Role of Macrophage Migration Inhibitory Factor (MIF) in KSHV-associated Malignancies

Kaposi’s Sarcoma-associated Herpesvirus (KSHV) is the etiologic agent of several human cancers, including
Kaposi’s Sarcoma (KS) and Primary Effusion Lymphoma (PEL), which preferentially arise in
immunocompromised patients (e.g., HIV+ personnel or organ transplant recipients) and lack of effective
therapeutic options. Despite the reduced incidence of KS in the era of combined Antiretroviral Therapy (cART)
for HIV infection, KS especially oral KS still remains one of the most common AIDS-associated tumors and a
leading cause of morbidity and mortality in this setting. PEL is a rapidly progressing malignancy with a median
survival time of approximately 6 months, even under the combinational chemotherapy. Macrophage migration
inhibitory factor (MIF) signaling activation have been found closely related to many cancer cell malignant
behaviors, however, its role in virus-associated cancers or how oncogenic viruses may regulate MIF signaling
activities remain largely unknown. We recently found high levels of MIF signaling activities during KSHV
infection or KSHV+ tumor cells in vitro and in vivo. Thus, we hypothesize that MIF signaling activation has
important role in KSHV pathogenesis and oncogenesis, which may represent a promising direction to
develop anticancer treatments for KSHV-related malignancies. To address this hypothesis, we propose
the following Specific Aims: 1) To determine the underlying mechanisms of MIF signaling activation within
KSHV+ tumor cells. 2) To develop MIF-targeted therapies against KSHV-related malignancies. Through these
efforts, we hope to determine the roles of MIF signaling activation in KHSV pathogenesis and induced
oncogenesis, and develop MIF signaling targeted therapies for improving the outcome of KSHV-related
malignancies in high-risk immunocompromised patients.

Public health relevance
Tumors etiologically linked to the Kaposi's sarcoma-associated herpesvirus (KSHV/HHV-8), including Kaposi’s sarcoma (KS) and Primary effusion lymphoma (PEL), are preferentially arising in immunocompromised patients but lacking of effective therapy. The current project aims to understand how Macrophage migration inhibitory factor (MIF) signaling activation contributes to KSHV pathogenesis, and development of MIF targeted therapies against these virus-associated malignancies.